Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) Administrative Core is a principal
organizational component supporting the coordination and management of the Senior Leadership and the
activities of the Research Programs, Shared Resources, Office of Cancer Health Equity, and Training and
Education. The Administrative Core has additional responsibilities for fiscal oversight of all WFBCCC functions
and ensuring cohesiveness and alignment with WFBCCC’s strategic goals and priorities. Specific Administrative
Core functions include Cancer Center Support Grant (CCSG) management; all Center-related financial and
human resources support, including the nine WFBCCC Shared Resources and the Office of Clinical Protocol
and Data Management; coordination with the WFBCCC philanthropic development team as well as the Office of
Cancer Health Equity; all internal and external communications; WFBCCC-driven cancer education and training
initiatives and outcomes tracking; and informatics support required to manage the CCSG and produce metrics
that are meaningful in evaluating the overall Center’s progress. Reporting to the WFBCCC Director, Boris
Pasche, MD, PhD, the Administrative Core is led by the Associate Director of Administration, M. Jennifer Kim,
MBA, in collaboration with a 16-member team of highly qualified and experienced individuals who oversee all
Center-related activities and foster an environment of collaboration and interaction among the WFBCCC
membership. The Administrative Core has accomplished a number of notable achievements in the current
project period, including: organizing and developing WFBCCC’s 2021-2026 Strategic Plan; facilitating the
reorganization of three of the WFBCCC research programs; coordinating the recruitment and start-up packages
for 47 new cancer-focused faculty; onboarding a new Shared Resource; organizing and supporting the
implementation of a Community Advisory Board and several new internal advisory entities; supporting the
proposal development of 12 funded CCSG supplements; designing and deploying a new data system to support
the collection of membership, training, and education outcomes data; and instituting new and revised policies
regarding membership and cancer relevance for grants and publications. The Administrative Core and Senior
Leadership are closely linked through frequent formal and informal meetings, and the Core coordinates the
efforts of external and internal planning and evaluation committees including: External Advisory Board,
Community Advisory Board, Internal Advisory Board, Executive Committee and its Space Management
Subcommittee, Scientific Leadership Council, Shared Resources Oversight Committee, Community Outreach
and Engagement Steering Committee, and the Cancer Research Training and Education Coordination Advisory
Committee. The Administrative Core has been instrumental to the continued success of this 45-year-old cancer
center and is well positioned to support the strategic efforts planned for the next project period, which will include
the research integration efforts with Atrium Health.